Determining the mechanism for YAP1 activation by HPV E7 in oropharyngeal carcinoma

PROJECT SUMMARY
Human papillomavirus (HPV) is a driver of carcinogenesis in oropharyngeal squamous cell carcinoma
(OPSCC). HPV infects epithelial keratinocytes and alters host cell signaling to suit viral replication. HPV
simultaneously promotes basal cell growth and represses cell differentiation programming causing increased
basal cell retention within stratified squamous epithelia and tumorigenesis from high-risk HPVs. The HPV
protein E7 is a major driving oncogenic factor responsible for promoting these effects. While it has been
documented that high-risk E7 causes degradation of host retinoblastoma tumor suppressor RB1, leading to
increased cell growth and DNA replication, RB1 degradation does not solely cause E7 tumorigenic activity. E7
activity is more tumorigenic than RB1 loss alone. In addition to growth stimulation, HPV requires repression of
cell differentiation. Our lab has documented E7 facilitates degradation of an additional tumor suppressor,
PTPN14. PTPN14 degradation by E7 represses cell differentiation and induces translocation of YAP1, an
oncogenic transcription coactivator. The mechanism connecting PTPN14 to YAP1 regulation is unknown.
My preliminary data indicates PTPN14 degradation by E7 suppresses YAP1 inhibition. Phosphorylation
of YAP1 at S127 coincides with YAP1 exclusion from the nucleus. YAP1 inhibition is induced by the Hippo
kinase cascade. I have shown PTPN14 loss is transformative and E7-mediated degradation promotes
dephosphorylation of YAP1 at S127. I have also shown PTPN14 induces YAP1 phosphorylation at S127. My
results show these effects in immortalized human foreskin keratinocytes and my goal is to apply my findings to
oral keratinocyte models. The specific aims of this proposal are to 1) determine if E7-mediated PTPN14
degradation promotes YAP1 dephosphorylation, stability and nuclear translocation in HPV positive
OPSCC and 2) determine the mechanism of YAP1 phosphorylation by PTPN14. In Aim 1 I will establish
effects of PTPN14 degradation in an oral keratinocyte cell model, quantifying phosphorylation levels of YAP1
and YAP1 stability by cycloheximide-chase experiments. I will test rescue of YAP1 inhibition on E7 knockdown
and also perform rescue experiments with an E7-binding mutant of PTPN14 to reestablish normal YAP1
regulation in HPV positive OPSCC cells. YAP1 localization in three-dimensional organoid cultures of OPSCC
cells will also be analyzed by immunofluorescence microscopy. In Aim 2 I will determine how PTPN14
promotes YAP1 S127 phosphorylation and subsequent nuclear exclusion in oral keratinocytes. PTPN14
mutants containing single deletions of function domains will be expressed with YAP1 phosphorylation
quantified by immunoblot. I will determine interactors of PTPN14 important for its ability to induce YAP1
phosphorylation by performing BioID biotin labelling of proteins under conditions of phosphorylated YAP1 and
dephosphorylated YAP1.

Public health relevance
PROJECT NARRATIVE Human papillomavirus (HPV) infection is responsible for a significant portion of oropharyngeal squamous cell carcinoma and the HPV E7 protein facilitates degradation of host tumor suppressor PTPN14, promoting activation and nuclear translocation of YAP1 oncoprotein in general keratinocyte models of head and neck squamous cell carcinoma. This activity of E7 leading to YAP1 activation by PTPN14 degradation has not been studied in oropharyngeal models of carcinoma and the overall pathway for PTPN14-dependent YAP1 regulation remains largely unknown. In this proposal I will determine if PTPN14 degradation by E7 is activating YAP1 in HPV-positive OPSCC cells and establish details of the mechanism for YAP1 phosphorylation and inhibition by PTPN14.